Diversity Supplement for Gabino Abarco to NIA R01AG061094

PROJECT SUMMARY
This is a proposal for an 18-month Diversity Supplement to fund hands-on research training and career
development for a talented public health graduate student in UCLA’s Fielding School of Public Health
Community Health Sciences Doctoral Program. The parent grant for this proposed supplement funds research
on the consequences of more physically strenuous work conditions that are more often experienced by Latino
workers in the US on the higher prevalence of physical limitations at older ages. During the Diversity
Supplement period, the graduate student will: (1) actively participate in the project’s collaborative research
group, (2) collaborate with project PI and other project group members on development, analysis, and
publication of at least 3 papers, (3) take the lead in all aspects of the research for at least one of these papers,
under the supervision of the PI, (4) submit and present a paper at either the Gerontological Association of
America (GSA) meetings or the Aging and Health Section sessions of the American Public Health Association
meetings, (5) enroll in two graduate-level courses on aging, and (6) receive regular individual mentoring on
training progress and career goals, and (7) attend the NIA-sponsored RAND Summer Institute on Aging in the
summer of 2022, if the Institute is held at that time.

Public health relevance
Project Narrative This diversity supplement to R01 NIA R01AG061094 will provide funding for UCLA Public Health graduate student Gabino Abarco to conduct research as part of the parent grant focusing on lifetime work experience and older age functional limitations for the Latino population. It also provides funding for training in aging and aging related research for the candidate.